Elucidating mechanisms underlying the pathogenesis of Hao Fountain Syndrome, a rare disease caused by USP7 variants

SUMMARY
Rare genetic diseases affect about 8% of the world's newborn population. Although current technological
advances in the exome and genome sequencing of patients with suspected genetic syndromes allow for
genetic diagnosis, most rare diseases have no treatment. Many rare disorders remain untreated because the
functional follow-up into the pathogenesis lags. This proposal addresses a rare condition, Hao-Fountain
syndrome HAFOUS, caused by mutations in the gene coding for the deubiquitinating enzyme USP7. We
determined that USP7 is a critical regulator of signals transmitted through the fundamental molecular axis of
the extracellular signal-regulated kinases 1 and 2 (ERK1/2) signal pathway. Based on this preliminary data, the
central hypothesis of this proposal is that hereditary USP7 variants lead to increased ERK1/2 activity, which,
during early morphogenesis, hampers the development of NC-derived tissues, leading to congenital
malformation in HAFOUS patients. We will test our hypothesis by pursuing two Specific Aims: 1) Elucidate the
effect of HAFOUS variants on ERK1/2 signal transmission in vivo and 2) Assess the effect of USP7 HAFOUS
pathogenic variants on embryonic tissue development. To investigate the in vivo effect of HAFOUS variants on
the early stages of embryonic development, we will use zebrafish as a vertebrate model. Zebrafish offer
distinct advantages for studies of embryonic development, including their transparency and their external and
rapid development. The proposed research applies our unique expertise and capacity to integrate zebrafish
with biochemical methodologies. In this project, we are poised to uncover a novel mechanistic effect of USP7
mutations on signaling outcomes associated with morphogenesis. The proposed work will establish preliminary
data critical for successful future studies focused on the strategies for therapeutic approaches addressing
USP7-linked abnormalities.

Public health relevance
Public Health Relevance Statement Rare diseases collectively affect approximately 25-30 million people in the United States and disproportionally affect children. The proposed work will result in a novel vertebrate model and novel insights into the pathogenesis of the rare developmental disorder associated with USP7 variants. Ultimately, this work will provide a model for the future development of guidelines for the diagnosis and treatment of Hao-Fountain Syndrome.